An Integrative Science Approach to Resilience: The Notre Dame Study of Health & Well-being

Abstract ? UH3057039 The NDHWB provides a longitudinal research design and powerful analytic strategies that can help researchers understand the interrelated themes of stress exposure, appraisal, reactivity, resistance, and recovery, thereby informing the role of the physiological stress response in cognitive impairment, and ultimately Alzheimer’s disease and Related Dementias. What is needed to understand the precursors of Alzheimer’s disease is explicit data on genotypes associated with Alzheimer’s disease, structural images of the brain, levels of Amyloid-β and indicators of brain functioning (using TMS-EEG) during cognitive tasks. In confluence, the proposed research provides an unprecedented opportunity to study with multiple methods the stressors to which adults are exposed, the resistance resources upon which they draw, and the emotional and physiological processes through which stress is manifested and eventually contribute to physiological dysregulation, cognitive decline and the development of Alzheimer’s disease.

Public health relevance
Project Narrative Our proposal is designed use a rigorous, multi-modal approach to assess AD risk that capitalizes on a unique, diverse, and valuable dataset -- the Notre Dame Study of Health & Well-being (NDHWB; NIA 2 R01 AG02357-06; UG3-UH3AGO57039). The NDHWB is a 15-year longitudinal study that continues to provide important insights into factors that influence wellness in older adults. Specifically, here we add innovative, neurophysiological biomarkers to predict risk for AD that are much less expensive and invasive than the current gold standard— biomarkers that will be used to identify at-risk individuals. This data-driven approach to early identification of AD risk could not be done without the 10 years of prior data on the study participants regarding their exposure and resilience to stress and the ongoing assessments of cognition, health and well-being. Broadly, we expect that increased stress exposure combined with decreased stress resilience will be predictive of increased presence of AD biomarkers. We will address this by investigate how stress exposure and stress resiliency during middle and later adulthood play an important role in the development of AD neuropathology.